COMPUTER AIDED TWO-DIMENSIONAL ELECTROPHORETIC GEL ANALYSIS

GELLAB is a computer based system of analysis of set of 2D gels. It incorporates sophisticated subsystems such as statistical, data base manipulation, image acquisition, etc. It has been applied to a variety of experimental systems in which quantitative changes in one or more proteins among hundreds or thousands of unaltered proteins is the basic analytic problem. During the year numerous extensions to the aramemetarium of procedures available to the user have been developed. It has also been applied to several new problems involving both early and late cellular differentiation and or protein synthesis. The objective of defining an exportable version of GELLAB (one that will run on a reasonably powerful microcomputer-affordable by a university deparment) is be actively pursued.